A Novel Fluorescence Imaging Platform to Predict Response to Combinatorial Tyrosine Kinase Inhibitors

PROJECT SUMMARY
Deregulation of kinase function in cell signaling pathways is implicated in numerous cancers. In response, kinase
inhibitors (KIs) have been developed to interact with these kinases for highly specific treatment. Though nearly
50 KIs have been FDA-approved, KI monotherapy is seldom curative, likely owing to tumor heterogeneity and
acquired resistance. For example, intra-tumoral heterogeneity can result in the treatment of sensitive cell sub-
populations, while simultaneously promoting the outgrowth of resistant “persister cells.” In response, effective
combination therapies must be tailored to known resistance mechanisms to efficiently engage with their targets
and exploit cellular vulnerabilities. However, standard drug screening tools (e.g., plasma analysis, western blot
[WB]) are bulk in nature, and no established technology exists to quantify KI target engagement, concomitant
with local protein expression, while assessing tumor response heterogeneity. To address these shortcomings,
our group has (1) developed protocols to fluorescently label KIs (and other small molecule therapeutics) that
mimic the native drug, (2) advanced a novel intracellular paired agent imaging (iPAI) platform to quantify drug
target availability (DTA) with these fluorescent KIs, and (3) established and validated a highly multiplexed im-
munostaining strategy utilizing DNA barcoded antibodies, enabling in situ cyclic immunofluorescence (cyCIF)
imaging. In this proposal, we will combine these three complementary innovations into a fluorescence imaging
platform we call TRIPODD (Therapeutic Response Imaging through Proteomics and Optical Drug Distribution
and binding). Herein, we will use TRIPODD to demonstrate the capability of iPAI to predict mono- and combina-
torial KI drug response and uncover drug resistance mechanisms across whole tumor specimens with single-
cell resolution. To achieve this, iPAI will be expanded to three-color imaging (i.e., two-drug DTA) while cyCIF will
be applied to monitor proteomic therapeutic response to gain a mechanistic understanding of clinically relevant
combination therapy outcomes. Epidermal growth factor receptor mutation positive (EGFRmut+) non-small cell
lung carcinoma (NSCLC), which currently lacks curative treatment, will serve as our model system. We hypoth-
esize that TRIPODD—as the first technology capable of comparing drug distribution and binding (iPAI) directly
to proteomic markers (cyCIF) at the cellular level—will be critical to uncovering salient mechanisms of therapeutic
response and resistance in NSCLC and ultimately enable tailored therapeutic strategy optimization based on
predictive algorithms. This hypothesis will be tested through the following specific aims: Aim 1: Demonstrate
that TRIPODD can quantify targeted KI-monotherapy response. Aim 2: Establish TRIPODD protocols to accu-
rately characterize KI-combinatorial therapy outcomes. Successful completion of this proposal will yield an opti-
mized fluorescence imaging toolbox (TRIPODD) that will provide an unprecedented view of the spatial correla-
tions between drug distribution/binding (iPAI) and the underlying tumor/microenvironment proteome (cyCIF),
enabling mechanistic understanding of NSCLC treatment strategies.

Public health relevance
PROJECT NARRATIVE The promise of molecularly targeted therapy for cancer patients has largely not been realized due to heteroge- neous resistance mechanisms, where targeted monotherapy typically results in short term response not long- term cure. Unraveling the complexities of therapeutic resistance is challenging because it is a complex interplay of drug distribution and target engagement as well as multifaceted and dynamic interactions between the tumor and its microenvironment. We have developed critical new tools (i.e., Therapeutic Response Imaging through Proteomics and Optical Drug Distribution and binding, TRIPODD) to quantify therapeutic efficacy and the corre- sponding resistance mechanisms to aid in crafting effective cancer treatment strategies.